STRUCTURAL BIOLOGY--IMAGE PROCESSING OF ELECTRON MICROGRAPHS

This project uses Image Processing techniques to analyze electron micrographs. In order to answer important questions in structural biology, it is necessary to obtain relatively high resolution two- and three-dimensional structural information about biological macromolecules. While atomic or near atomic resolution information has traditionally been available by x-ray crystallography for some small molecules and small proteins, the overwhelming majority of biological macromolecules are not crystalline, or are too large and therefore not amenable to 3-D crystallography. Biological specimens can, on the other hand, be visualized in the electron microscope using a number of specimen preparation techniques. Cryo- electron microscopy, for example, attempts to preserve 'native' structure by surrounding the specimen in a layer of ice. Collaborative research with LSBR, NIAMS is currently underway on a number of projects whereby the e.m. images are computationally corrected, combined, average, reconstructed, or in some way computationally enhanced in order to improve the signal-to- noise ratio or increase the interpretability of the structures being visualized.